IGF::OT::IGF Hispanic Community Health Study - Study of Latinos HCHS-SOL) Ech

The National Heart, Lung, and Blood (NHLBI) at the National Institutes of Health (NIH) is establishing the Echocardiography Reading Center as part of the Hispanic Community Health Study (HCHS-SOL). The Echocardiography Reading Center is responsible for the various tasks related to the echocardiography measures to be collected and assessed in the HCHS-SOL Visit 2 and annual follow-ups.